Investigating the mechanism of SHP2 and BCL2 Inhibition in Acute Myeloid Leukemia (AML)

PROJECT SUMMARY/ABSTRACT
Background: Mutations in receptor tyrosine kinase (RTK) signaling genes such as Fms-Like
Tyrosine Kinase 3 (FLT3) and the KIT proto-oncogene occur in two-thirds of acute myeloid
leukemia (AML) and are associated with high relapse rates. FLT3 tyrosine kinase inhibitors
(TKIs) are clinically active in FLT3-mutant AML but duration of response is limited by the
development of resistance due to re-activation of RAS signaling. No specific proven therapy
exists for these relapsed patients or patients with other signaling mutations. Rationale: The
protein tyrosine phosphatase SHP2 is a central node in RAS activation and propagation of
growth factor signals. SHP2 modulates MAPK pathway activation downstream of RTKs but the
full molecular mechanisms of SHP2 activity are not clear. Small molecule allosteric inhibitors of
SHP2 such as RMC-4630 stabilize the closed, autoinhibited conformation of SHP2 and are in
clinical development. The goal of this application is to leverage new allosteric SHP2 inhibitors
(SHP2i) to elucidate the molecular role of SHP2 in RTK-mediated survival in AML and test the
efficacy of SHP2i in combination with the BCL2 inhibitor (BCL2i) venetoclax. Methods: We will
test the therapeutic efficacy of SHP2i in combination with BCL2i in FLT3 and KIT mutant AML.
We will use single cell multiomic sequencing to discover biomarkers of response and resistance.
Using biochemical and proteomic approaches, we will assess the effect of SHP2i on RTK
signaling in FLT3 and KIT mutant AML cells and associated effects on apoptosis. We will
isolate the role of RAS/MAPK transcriptional activation in SHP2-mediated survival and
determine the role of SHP2 in adhesion-mediated survival signaling in RTK-driven AML.
Expected Results: We anticipate that these studies will uncover new knowledge about the role
of SHP2 in leukemic cell survival and facilitate rational development of SHP2i combination
therapies, particularly in combination with BCL2i. The overall goal of this work is to develop
SHP2 inhibitor therapy as a novel treatment strategy in RTK-driven AML.

Public health relevance
PROJECT NARRATIVE This research focuses on acute myeloid leukemia (AML), which affects more than 10,000 Americans annually, the majority of who die of their disease within a short time. This research addresses the role of SHP2 in receptor tyrosine kinase signaling in relapsed/refractory AML and the use of SHP2 inhibitors in combination with BCL2 inhibitors in AML treatment. The overall goal of this work is to establish new and effective strategies to treat relapsed/refractory AML.